Preparation of a Phase I/II safety and efficacy trial for a cholera phage cocktail intervention

Project Summary
The World Health Organization (WHO) estimates that approximately 1.3 billion people globally are at risk for
cholera, a severe diarrheal disease caused by the bacterium Vibrio cholerae that is spread through contaminated
water sources and substantial secondary person-to-person transmission. In 2022, the world saw a surge in the
number of cholera cases and associated deaths. Over 29 countries reported outbreaks with the highest recorded
global case fatality ratio of 1.9% (2.9% in Africa) in over a decade. Of note, 13 of these countries did not report
cases in 2021 and had not seen cases between 3 and 30 years, severely disrupting the disease elimination
goals of the WHO Global Taskforce for Cholera Control. Current prevention methods, such as the oral cholera
vaccine (OCV) and water, sanitation, and hygiene (WASH) campaigns, require significant investment of
resources and time for efficacy, but household contacts of cholera patients often present with cholera symptoms
two to three days after the initial patient becomes sick. In addition, the preventive use of antibiotics is not
recommended due to widespread resistance for cholera and other pathogens in the same environment. There
is a pressing need to develop a targeted clinical intervention to prevent the community spread of cholera using
a fast-acting prophylactic treatment. PhagePro aims to fill this gap with its product ProphaLytic-VcTM (PVC). PVC
is an orally administered bacteriophage (phage) cocktail comprised of Vibriophages ICP1, ICP2, and ICP3.
In this R34 clinical trial planning proposal, we aim to partner with cholera physicians and researchers at the
International Centre for Diarrhoeal Diseases Research, Bangladesh (icddr,b) to plan for the first-in-human Phase
I/II trial for PVC to demonstrate safety and efficacy in household contacts of cholera patients. Phase I will test
once or twice daily oral doses of PVC, self-administered, for 7 days. Each arm will have 10 healthy adult
volunteers. After safety has been assessed, Phase II will commence with household contacts of cholera patients
with daily doses of either a placebo or PVC for 7 days. Each arm will have ~224 volunteers. We hypothesize
there will be at least a 43% reduction in cholera incidence among household contacts. To successfully implement
this trial, we will perform the following activities during the R34 grant.
First, we will develop clinical trial documentation such as the Clinical Protocol, Manual of Procedures,
Investigator’s Brochure, site management documents, data management plans, and tracking/monitoring
documents. In addition, we will recruit needed expertise such as biostatisticians, clinical operations associates,
quality control/assurance specialists, and Clinical Research Organizations to support these activities. Second,
we will develop a regulatory plan for administration of PVC in Bangladeshi volunteers, which involves submitting
materials to the icddr,b Institutional Review Board, Ethics Review Committee, Bangladeshi Medical Research
Council, and Directorate General of Drug Administration. To ensure timely success, PhagePro will be using
project management strategies for successful completion of deliverables.
At the successful conclusion of the R34 grant, we will have established all the necessary documentation and
submitted the relevant materials to Bangladeshi regulatory authorities for successful approval of the Phase I/II
clinical trial for PVC.

Public health relevance
Project Narrative This proposal aims to plan the first-in-human Phase I/II clinical trial of a phage-based clinical intervention, ProphaLytic-VcTM (PVC), to prevent the community spread of cholera in Dhaka, Bangladesh. With the successful completion of prior small business grants, PhagePro has demonstrated that PVC is highly effective in preventing Vibrio cholerae colonization of the small intestine in mice and rabbits, thus protecting against cholera. We have established robust small-scale phage manufacturing parameters, optimized critical quality control assays, constructed an avirulent V. cholerae manufacturing strain, and completed Investigational New Drug (IND)- enabling studies aligned with the FDA’s expectations for phage products. With Serán Bioscience, we have optimized small-scale processes for solid dosage formulation of each PVC phage. With this R34 clinical trial planning proposal, we aim to collaborate with cholera physicians and researchers at the International Centre for Diarrhoeal Diseases Research, Bangladesh (icddr,b) to develop documentation to support successful implementation of the Phase I/II trial for safety and efficacy of PVC in household contacts of cholera patients. In addition, we will develop a regulatory plan in alignment with Bangladeshi authorities and the U.S. Food and Drug Administration. If successful, the clinical trial will demonstrate proof-of-clinical efficacy for PVC and the potential for PVC to be a transformative tool in controlling cholera outbreaks around the world.